Synthesis of Sensitive Epitranscriptomically Modified RNAs

Project Summary is the same as that for the parent award (2R15GM109288-03), and should not be submitted
for this Administrative Supplement application according to PA-20-272.

Public health relevance
Project Narrative is the same as that for the parent award (2R15GM109288-03), and should not be submitted for this Administrative Supplement application according to PA-20-272.